Explaining State Variability in Pediatric Hospitalizations and Reported Child Maltreatment

Children from families with low socioeconomic status (SES) have diminished health and well-being compared
to children from families with higher SES, including higher rates of hospitalizations and child maltreatment.
SES is multidimensional and, for children, includes family income. The investigators recently discovered
substantial variability across states in the relationship of family income with rates of both pediatric
hospitalizations and child maltreatment. State safety net policies, by supporting families with low income, may
explain this variability. However, there has been no previous research on whether state safety net policies are
associated with hospitalizations for either children or adults. Along with others, the investigators demonstrated
at the state level that safety net policies are associated with reduced rates of child maltreatment, but the
precision of that work was limited by state level ecological approaches. Their preliminary data suggests that
the form of these policies — as either “bolus” or “continuous” supports — may be a critical and modifiable
aspect of their impact. Three state policies act as an income “bolus” for families via annual one-time income
support. In contrast, state minimum wage policies act as a “continuous” income support across the year. The
investigators will exploit the variability in these state policies to determine their associations with two
dimensions of child well-being: physical and mental health (hospitalizations) and adverse childhood
experiences (child maltreatment). Their approach overcomes the limitations of prior state level ecological
analyses, allowing them to examine the impact of the policies at the level of Census public-use microdata
areas (PUMAs) and counties. They have three specific aims: (1) Create a publicly available dataset of four
state safety net policies that adheres to the highest standards of legal research in all 50 states from 2000-
2020. Then, to determine if state variability in three “bolus” policies and one “continuous” policy are associated
with (2) all pediatric hospitalizations by merging 225 AHRQ HCUP State Inpatient Databases from all states
that have the patient’s home zip code (n=15) every year during a 15-year period (2005-2019) and (3) all
reports of child maltreatment investigated by Child Protective Services from all 50 states in the National Child
Abuse and Neglect Data System (NCANDS) every year during a 15-year period (2005-2019). The study will
also explore the relationship of these policies with pediatric ED visits and specific diagnoses which may be
more sensitive to the policies’ effects. The proposed research is significant because it will fill a critical
knowledge gap on the relationships of specific safety net policies with pediatric hospitalizations and
maltreatment. The proposed research is innovative because it is the first study to examine the impacts of
safety net policies on hospitalizations, the first to examine the form of such policies (i.e., bolus vs. continuous),
and it overcomes imprecise state-level methodological limitations through the examination of outcomes at the
PUMA and county levels.

Public health relevance
Project Narrative The proposed research is relevant to public health because it seeks to identify policies which result in improved health and wellbeing in children from marginalized populations. The project is relevant to the mission of the Eunice Kennedy Shriver National Institute of Child Health and Development by helping to ensure that all children have the chance to achieve their full potential for healthy and productive lives. This research supports the mission of the National Institutes of Health by creation of knowledge (and resources for future investigations) that will reduce pediatric hospitalizations and child maltreatment by identifying policies capable of mitigating the negative influences of low socioeconomic status.